The function role of salivary piRNAs in oral wound healing

PROJECT SUMMARY/ABSTRACT
The oral mucosa is constantly exposed to a bacteria-rich environment coupled with continual physical trauma.
For patients, chronic oral wounds aren't merely an inconvenience. They can impair nutrition intake and pose a
substantial risk of debilitating infections, marking a significant oral health challenge. Defining factors involved in
oral wound healing would allow the identification of novel therapeutic targets to improve tissue repair. Oral wound
healing has long been considered a model of optimal wound resolution characterized by rapid and scarless
wound healing. However, the intrinsic genetic and epigenetic controlling mechanisms that make oral mucosa
highly adaptable to accelerated healing upon injury remain unclear. An important aspect of healing is re-
epithelialization, which entails both proliferation and migration of keratinocytes at the periphery of the wound.
Understanding the role and function of keratinocytes in re-epithelialization will benefit patients with chronic
wounds.
We recently identified a previously unnoticed landscape of non-coding RNA in saliva and found piwi-interacting
RNA (piRNA) is surprisingly abundant in saliva. Of particular interest are three distinctive oral-piRNAs that are
uniquely present in saliva and oral keratinocytes and appear to contribute to the oral wound re-epithelialization
phenotype. The preliminary data involving inhibition of oral piRNAs concomitant with a failure of wounds to heal
in a timely fashion suggests that these small RNAs may play a significant role in mediating wound healing. The
overarching hypothesis of this proposal is that oral-piRNAs are intrinsic factors in human oral keratinocytes, that
modulate the rate of wound closure. Two specific aims are in place to further characterize the wound healing
phenotype and elucidate the cellular factors responsible for oral-piRNA-mediated phenotypes. Aim 1 is to
investigate the role of saliva piRNAs on oral wound re-epithelialization using 3D ex vivo and in vivo oral wound
healing models. Aim 2 is to elucidate the mechanism by which piRNAs regulate oral wound healing. This proposal
aims to unravel how these novel oral-piRNAs accelerate human oral keratinocyte proliferation and migration,
which may improve wound healing therapeutic developments. The long-term goals of this proposed study are to
enhance our understanding of the biological roles of piRNA relevant to human oral health and diseases and
leverage these findings to improve wound healing outcomes for patients.

Public health relevance
PROJECT NARRATIVE The proposed research will investigate the biological functions of salivary piRNA in relevance to intraoral wound healing via activation of transposon methylation in oral mucosal epithelial cells. Functionally characterize piRNA with respect to normal physiological functions will provide more definitive insight into the molecular mechanisms of the unique phenotypical properties of oral wound healing and improve oral health therapeutic developments.